TISSUE SPECIFIC INSULIN REGULATION OF LIPOPROTEIN LIPASE IN NIDDM

the purpose of this study is to examine the relationship of lipoprotein lipase in adipose tissue and skeletal muscle of subjects with non-insulin-dependent diabetes and the tissue-specific responsiveness of LPL to insulin.